Core A (Administrative Core)

Project Summary – Core A
The Administrative Core (Core A) guides and supervises the overall Program Project research effort. The
Director has ultimate responsibility for supervision of Program Project activities. The Director is assisted by the
Co-Director. An important function of the Core is to organize and schedule bi-monthly meetings of all Program
Project personnel and maintain written records of these meetings. Frequent meetings documented with
reports presented by Project and Core Leaders ensure that all projects are meeting Program goals. Project
and Core Leaders meet separately at least once a month to discuss progress, trouble-shoot scientific or
technical issues and make policy decisions. Electronic records of all group meetings are available to Program
personnel through a Program Project Electronic Group (Teams). Microsoft Teams allows for easy, group
specific communication of text, images, documents, etc. Core A communicates with the Internal and External
Advisory Committees. These committees monitor Program Project research progress and provide evaluations
and critiques of the group effort. They also assist the Director in developing solutions to any research-related
problems that may arise, and they give the Director leverage to help hold the overall Program Project
accountable for the proposed work. Core A is responsible for monitoring Program expenditures, including
travel by Project Leaders, and routine bookkeeping. Publication costs arising from Program Project-funded
research will be processed through individual projects. Finally, Core A handles assembly and submission of
annual progress reports with continual encouragement for investigators to be active at scientific meetings that
helps promote and integrate their findings into scientific knowledge. Core A is overall responsible for the
service to, training of and development of PPG personnel.